Training for Research Excellence and MeNtorship in Tuberculosis (TRENT)

ABSTRACT
This proposed University of California, San Francisco (UCSF) / University of California, Berkeley
(UCB) / University of Zimbabwe (UZ) Fogarty HIV research training program renewal (Training
for Research Excellence and meNtorship in Tuberculosis (TRENT)) will provide multi-disciplinary
training to University of Zimbabwe, College of Health Sciences (UZCHS) junior scientists in order
to strengthen capacity and promote high quality, innovative, and locally relevant HIV/TB research.
Building on decades of collaboration in HIV/AIDS-related research and training, this sixth renewal
of our AITRP will have clinical research, translational research, and implementation science-
specific training tracks, each with its own dedicated faculty. In addition, in this renewal we aim to
capacitate local established HIV networks (i.e., the UZ-UCSF Clinical Trials Unit, host to ACTG,
HPTN, MTN, and IMPAACT-sponsored trials) through development of a clinical trials specialist-
training track. The proposed training program will target pre- and post-doctoral trainees, aiming
to augment and strengthen the research training available in multiple departments of UZCHS (e.g.
Medicine, Dentistry, Medical Microbiology, Pediatrics and Child Health, Community Health, and
Obstetrics and Gynecology) in both the short and long term. Trainee candidates supported by this
program will be current UZCHS pre-doctoral students or post-doctoral scholars, many who will
have been trained in previous funding cycles by our AITRP or complementary training programs;
or individuals currently working within the Ministry of Health or implementing partner providing
HIV/TB prevention or treatment services in Zimbabwe. Trainees will undertake dissertation
research projects with UZCHS, supplemented by extensive enrichment via UCB and UCSF; or in
conjunction with UZCHS partner organizations, Biomedical Research and Training Institute and
the London School of Hygiene and Tropical Medicine. Trainees successfully completing their
dissertation research projects will be eligible to compete for modest funding for their onward
academic projects at the time of junior faculty onboarding within UZ. All trainees will receive
training in the ethical issues involved when planning, conducting, and analyzing the results of
human research studies. The result of the training program will be an increase in the number of
advanced students and faculty in multiple departments of UZCHS conducting high quality
HIV/AIDS- and TB-related research that is locally relevant and that contributes to enhanced
prevention and treatment programs.

Public health relevance
PROJECT NARRATIVE The proposed training program will provide HIV/TB-related research training in conjunction with and support of the University of Zimbabwe's College of Health Sciences, in Harare, Zimbabwe. The training program will strengthen both the trainee pipeline and faculty of the College of Health Sciences of the University of Zimbabwe, which has been severely diminished over the past decade by economic and social problems in Zimbabwe. The goal of the proposed training program is to augment both the number and the ability of the faculty of the College of Sciences to conduct locally relevant HIV/AIDS-related research in support of the successful implementation of HIV/TB prevention and treatment programs.